A digital health intervention to increase condom use among adolescent sexual minority males

PROJECT SUMMARY/ABSTRACT
Career Goal: I am committed to a career as an independent research scientist contributing to the design,
implementation, and evaluation of interventions to improve sexual health among adolescents, and reduce
disparities in health outcomes. Career Development: This K99/R00 Award will provide an additional period of
mentored training to support my transition to an independent investigator by the end of the K99 phase. My
training objectives are to: (1) master methodological strategies for conducting formative research necessary for
health intervention adaptation and tailoring; (2) gain a proficient understanding of adolescent sexual minority
male (ASMM) health and sexual assertiveness training needs; (3) identify core principles and applications of
implementation science to successfully conduct a clinical trial with an effectiveness-implementation hybrid
design; and (4) develop skills and expertise to facilitate a successful transition into a fully independent research
scientist, including those needed to conduct randomized controlled trials of behavioral interventions. Research
Project: ASMM are at disproportionately high risk for acquiring HIV/STIs and report lower rates of condom use
compared to their heterosexual peers. Assertive sexual communication is associated with higher rates of
condom use among adolescents; however, ASMM do not receive adequate information or skills about sexual
assertiveness. The purpose of this research is to adapt an existing digital health intervention, originally
designed to provide a general population of teens with information about sexual consent, to include a focus on
condom negotiation and tailor content specifically for ASMM. The project has two Specific Aims: (1) adapt the
sexual consent intervention (PACT) to serve as skills-based sexual assertiveness and condom negotiation
training for ASMM; and (2) evaluate the adapted PACT intervention among ASMM in an effectiveness-
implementation hybrid design. Mentorship: I have assembled a dedicated mentoring team of experts to
provide ongoing guidance on my proposed research and training activities. This team includes a primary
mentor (Dr. Eric Walsh-Buhi, Department of Applied Health Science, Indiana University School of Public
Health-Bloomington [IU SPH-B]), a secondary mentor (Dr. Kathryn Macapagal, Department of Medical Social
Sciences, Northwestern University’s Feinberg School of Medicine), and a panel of scientific advisors in the
Department of Applied Health Science at IU SPH-B (Drs. Kristen Jozkowski, Karla Galaviz, and Debby
Herbenick). Future Directions: Skills and data acquired from this proposal will support a future R01 proposal
to conduct further trials of PACT.

Public health relevance
PROJECT NARRATIVE Assertive sexual communication is linked to higher condom use rates, and, in turn, lower rates of human immunodeficiency virus (HIV) and sexually transmitted infections (STIs). However, adolescent sexual minority males (ASMM), a population disproportionately at-risk for acquiring HIV/STIs, do not receive adequate information or skills surrounding assertive sexual communication with a partner. The proposed project will help us adapt an existing digital intervention to increase sexual assertiveness among ASMM, with a specific focus on condom negotiation, to increase condom use rates.